Sex-biased impacts of 16p11.2 variants on reward-guided choice

Project Summary
Sex and gender are potent influencers of the etiology, presentation, and prognosis of essentially every
neuropsychiatric disorder. However, we have a fundamental gap in knowledge in understanding how sex
interacts with other contributors to neuropsychiatric risk, such as genetic variants. These genetic variants may
not have the same biobehavioral impacts across male and female brains. One such genetic factor, copy
number variation at the 16p11.2 locus, is strongly associated with a broad spectrum of male-biased
neurodevelopmental diagnoses, including autism and psychosis at the level of genome-wide significance. Male
mice with a hemideletion at the syntenic 16p11.2 locus display profound alterations in reward-guided decision
making and striatal biology, but these are substantially mitigated in female mice carrying the same
hemideletion. This animal model is thus ideally positioned to reveal how sex interacts with genetic factors that
alter neurodevelopment to produce male vulnerability. Strong evidence implicates striatal circuits in reward-
guided choice behavior. We will pursue three Aims assessing whether altered functional activation of striatal
circuits in male 16p11.2 hemideletion animals, in comparison with wildtype males and 16p11.2 hemideletion
females, provides explanatory power for behavioral alterations in these males. In each case, we will test
whether sex differences in striatal circuit function interact with or mitigate the impact of 16p11.2 hemideletion
on these circuits. In Aim 1, we will measure dopamine inputs into the dorsomedial striatum and nucleus
accumbens core during decision making to determine if these signals are leading to striatal dysfunction in
males, and if dopamine release in females is normalized. In Aim 2, we will measure medium spiny neuron
outputs from the dorsomedial striatum and nucleus accumbens during the same decision epochs to determine
what aspects of choice and reward are being signaled in 16p11.2 hemideletion males versus females. Finally
in Aim 3, we will expand our scope to measure functional connectivity to the striatum across the brain using
resting state functional magnetic resonance imaging, asking in particular if cortical inputs to specific striatal
compartments are impacted by 16p11.2 hemideletion in a sex-dependent manner.

Public health relevance
Project Narrative There are large sex differences in neurodevelopmental disorders, thought to result in part from sex differences in the effects of associated genotypes. Using touchscreen cognitive testing in mice, we will explore whether sex differences in the effect of a genetic variant seen in neurodevelopmental disorders on cognition are the result of male-specific changes in function in neural circuits involved in representing rewards and choices.